MEDICAL RISK AND COMPLICATIONS OF OBESITY GENES

The purpose of this study is to describe the genetics, family structure, incidence of obesity and of medical disorders in a group of people who have had a history of obesity.